Application of Data Science to Build Research Capacity in Zoonoses and Food-Borne Infections in West Africa

ABSTRACT
The importance of Health Data Science in Africa cannot be overemphasized, as the burden of
infectious and non-infectious diseases is striking across the continent. Despite this, health data
science in Africa is grossly underdeveloped, which is mainly due to lack of well-trained data
scientists. In the last few years, there have been efforts to address the Data Science training
needs in Africa. However, these remain limited in scope and some of the crucial infectious
diseases such as zoonoses and food-borne infections, which take a significant toll on the
continent, have not been sufficiently addressed. The aim of the proposed training programme is
to enhance research into zoonoses and food-borne infections in West Africa through the
application of data science. We are proposing three training tracks as follows: (I) To provide a
one-year research training to MSc students in West Africa. In this training track, we will support
training of excellent candidates who have completed the first-year course work of a relevant MSc
programme. The candidates will undertake a research project on a topic that applies
bioinformatics, phylodynamics, and/or disease modelling to zoonoses or foodborne infections for
their dissertation. (ii) To provide a one-year research training to faculty members from West Africa.
In this training track, we will support early career scientists/faculty from universities and research
institutions who are interested in developing a research career in zoonoses or foodborne
infections. They will apply bioinformatics, phylodynamics and disease modelling tools in research
on zoonoses and food-borne infections. (iii) To organize workshops to provide hands-on training
in bioinformatics, phylodynamics and disease modelling to wider communities in West Africa. The
long-term goal is to establish a core of West African scientists who can carry out rigorous health
research projects using data science.

Public health relevance
PROJECT NARRATIVE The aim of the proposed training program is to enhance research into zoonoses and food-borne infections in West Africa through the application of data science. The training program provides one-year research training to MSc students and faculty members in West Africa, as well as organizing training workshops to wider communities in the sub-region.